Research Education Core

PROJECT ABSTRACT: RESEARCH EDUCATION CORE
The primary objective of the Research Education Core (REC) is to support the Dartmouth Learning Health
System (LHS) Embedded Scientist Training and Research (E-STaR) Center by providing LHS scientists with a
tailored program of learning to support the conduct of patient-centered outcomes research (PCOR) and
comparative effectiveness research (CER) within a LHS context. This begins with intentional recruitment and
selection of a diverse group of scientists through a national call for applicants whose research interests are
aligned with advancing rural health equity. Understanding candidates’ research skills and experience working
within clinical settings will be essential to crafting the best educational pathway and selecting the most
appropriate mentorship team. The Center has a deep pool of mentors to draw upon, and faculty with years of
experience in PCOR/CER and LHS. All scientist’s training will begin with the Partnership Academy, two-day,
experiential training on community engagement in rural health equity for medically underserved populations.
An assessment of scientists’ knowledge and skills as they pertain to LHS competencies and PCOR/CER
methodologies will guide creation of a tailored training plan to be carried out over 18 months. This will include
selected didactic content, a LHS seminar series, experiential learning involving a research project supported by
the Research and Data Analysis Core (RDAC), and participation in a Learning Collaborative.
The REC’s Specific Aims are:
Aim 1: To intentionally recruit and guide a diverse cohort of embedded scientists.
Aim 2: To develop and evaluate a training program that delivers needs-based, tailored professional
development plans based on LHS core competencies and PCORI methodology standards for LHS scientists.
Aim 3: To create a community of practice that will support scientists as they develop their research,
improvement, and implementation skills with cross-team experiential immersion in ongoing LHS development.
The REC, working in concert with the RDAC and the Center’s Administrative Core, will train the next
generation of LHS scientists with essential knowledge for conducting rigorous and reproducible PCOR/CER
and effectively implement evidence-based practices within the LHS context.